cis-Acting Elements Regulating Developmental Control of Replication Timing

PROJECT SUMMARY / ABSTRACT
DNA replication is central to the structural and functional integrity of the genome and intimately tied to large-
scale 3D chromosome organization, cell lineage specification and disease, but we understand little about its
regulation. We have identified specific cis-elements, termed Early Replication Control Element (ERCEs), that
are essential for replication timing (RT), chromosome architecture, and transcription in murine embryonic stem
cell (mESCs). These novel elements likely coordinate the major correlated features of large-scale chromosome
structure and function, underscoring an urgent need to understand how they function and whether they can be
exploited in human health and disease. Our long-term goal is to understand the relationship of RT to chromo-
some architecture, epigenetic states and disease. Our immediate goal is to identify mechanisms by which
ERCEs co-regulate RT, chromatin architecture and transcription. ERCEs harbor acetylated histones, form
CTCF/cohesin-independent 3D interactions and are co-occupied by pluripotency transcription factors Oct4,
Sox2 and Nanog (OSN) in mESCs. Preliminary data show that their activity is DNA sequence encoded and
can be transferred to ectopic sites to manipulate RT. Our central hypothesis is that lineage-specific transcrip-
tion factors bind to ERCEs and seed a sub-nuclear microenvironment that potentiates early RT, which in turn
drive modifications in chromatin and genome architecture. Our rationale is that elucidating mechanisms by
which ERCEs co-regulate RT with transcription and genome architecture will open new horizons for studies of
chromosome structure and function, ultimately providing tools to correct RT aberrations in disease states and
to develop more robust cellular therapeutics. Aim1 will identify sequence motifs and trans-acting factors under-
pinning ERCE activity, a critical first step to probe mechanisms regulating RT and to develop tools to manipu-
late RT. Aim2 will examine mechanisms by which multiple ERCEs cooperate to elicit large changes in RT and
the structural and functional consequences of altering RT to the engineered chromosome domain. Aim3 will
clarify the longstanding enigmatic relationship between RT and transcription during cell fate transitions. This
contribution will be significant because it will lift a major barrier to the study of mechanisms regulating chromo-
some structure and function, how they are regulated during cell fate transitions and, ultimately, how they are
mis-regulated in human disease. This work is innovative because the breakthrough discovery of ERCEs intro-
duces novel hypotheses, concepts and approaches to the genome-architecture field.

Public health relevance
PROJECT NARRATIVE The proposed project is important for public health because abnormalities in the temporal order in which chro- mosome segments are duplicated have been detected in many diseases, yet this replication timing process remains one of the most poorly understood chromosomal functions. The proposed experiments build on recent breakthrough discoveries that make possible for the first time a genetic analysis of replication timing that is cer- tain to have major impact on our understanding of how replication timing is regulated and suggest novel thera- peutic tools. Thus, the proposed experiments are relevant to the part of NIH’s mission that pertains to develop- ing fundamental knowledge that will increase our understanding of the pathogenesis of disease.